REMISE study: REMnant biospecimen Investigation in SEpsis

PROJECT SUMMARY / ABSTRACT
Almost 2 million Americans are hospitalized with sepsis each year, and nearly one in five
don’t survive. Most efforts to reduce sepsis deaths begin with the premise that patients
are largely similar, and that targeting therapeutics to a single mechanism will improve
outcomes. But sepsis patients differ in pathogen, biology, outcomes, and are proposed
to have treatment responsive endotypes. Greater study of sepsis endotypes has been
limited by costly infrastructure and biospecimen collection that is not scalable. To solve
this challenge, we will use a clinical remnant biorepository to understand feasibility,
integrity, and scientific value for mechanistic sepsis research. We will evaluate traditional
biomarkers, quantitative proteomics, metabolomics, lipidomics, and pathogen genomic
sequencing in remnant specimens and graduate successful data “layers” to a scaled,
community hospital repository. This cross-cutting project will be supervised by an
external advisory board with expertise in inflammation, immunology, computational and
systems biology, and laboratory and pathology medicine. This approach will further
develop our NIGMS-funded clinical-translational laboratory, creating new hypotheses
from a diverse, academic and community hospital remnant biorepository acquired from
an endotype-enriched population of sepsis patients. Finally, we will further integrate
these data with multi-omics read-outs in severely injured trauma patients to explore
shared/unshared mechanisms in critical illness.

Public health relevance
PROJECT NARRATIVE Clinical remnant biospecimens are common, but typically wasted. These remnant biospecimens are understudied and of uncertain scientific value to inform the biology of sepsis. With further evaluation of integrity and feasibility, clinical remnant biospecimens may be a scalable approach uncover mechanisms that inform sepsis treatment.